PHASE II EVALUATION OF LOW DOSE ETOPOSIDE FOR KAPOSI'S SARCOMA

Phase II evaluation of low-dose oral etoposide for the treatment of relapsed or progressed AIDS-related Kaposi's Sarcoma after systemic chemoth apy.